2024 Annual Conference Grant: American Society of Preventive Oncology

ABSTRACT
The mission of the American Society of Preventive Oncology (ASPO) is the exchange and translation of scientific
information to reduce the cancer burden and for the continued development of investigators involved in cancer
prevention and control. The 48th ASPO Annual Meeting will be held at the Swissôtel Chicago, March 17-19, 2024.
The specific aims of the annual meeting and this conference grant are to: 1) provide multidisciplinary forums for the
exchange of scientific information; 2) foster implementation and broaden dissemination of scientific discoveries; and 3)
provide exceptional professional development to investigators at any career stage, but especially early career
investigators, to maximize their potential for success.
This application requests partial support for the 2024 Annual Meeting, which is a keystone of this multidisciplinary
organization and the preventive oncology community. ASPO’s annual meeting provides a high-quality program that
fosters new opportunities for early career, mid-career, and senior investigators whose careers are focused on the
primary, secondary, and tertiary prevention of cancer.
The 2024 Meeting consists of 4 symposia, 2 lunch roundtable sessions, 2 award lectures, 4 Special Interest Group
breakfast sessions, a networking mixer, two poster sessions, and a Community Science program that fosters community
engagement. As we near ASPO’s 50th anniversary, this year we added a new session type - a new format we are calling
“Looking back, thinking forward”, these sessions are kicked off by a senior investigator and followed by 4 junior
investigator or trainee flash talks selected from abstract submissions. Pre-meeting workshops include multiple
professional development sessions, a meeting of cancer center Associate Directors and Program Leaders for Cancer
Prevention and Control, and a meeting for NCI training grant directors.
Meeting planning takes satisfaction surveys from previous annual meetings into account. Abstracts will be solicited
beginning in August 2023. The 16 abstracts receiving the highest peer reviewed rankings will be published in Cancer
Epidemiology, Biomarkers & Prevention, and presented during paper sessions and the poster session.
Multiple initiatives including this conference grant—which requests travel support for minority investigators, early
career scientists, and community scientists/advocates—enhance the diversity of the meeting attendees, program
committee, and invited speakers. All meetings are held in non-smoking, ADA accessible conference facilities. Journal and
online advertisements, email, and direct mail will publicize the meeting. Over 400 participants are expected to attend.
Speakers and participants are from multiple disciplines in cancer prevention and control research and represent fields
concerned with translating evidence into effective prevention and control programs. By fostering communication among
multidisciplinary professionals, ASPO meetings have been extraordinarily successful at reaching the Society’s goals of
supporting mentoring, encouraging dialogue, and promoting innovative progress in cancer prevention and control.

Public health relevance
Project Narrative - Public Health Relevance The American Society of Preventive Oncology (ASPO) is a distinctive society that emphasizes multidisciplinary approaches to cancer prevention and control research. ASPO fulfills a unique niche enhancing the health of the public and supporting the continued development of investigators involved in cancer prevention and control. This application requests partial support—including travel funds for minority and early career investigators and community scientists/patient advocates—for ASPO’s 48th Annual Meeting, to be held at the Swissôtel Chicago, March 17-19, 2024. The events and activities available at ASPO’s 2024 Annual Meeting will influence scientific collaboration and cancer communications and community engagement beyond the conference.